Peptides and small-molecules targeting signaling proteins and protein-protein interfaces

Cell-surface receptors and intracellular regulatory proteins are preeminent mediators of cellular signaling.
These proteins are involved in a host of interactions and pathways, so various stages of their signaling cycles
provide opportunities for unique therapeutic intervention. However, the conventional approaches of directly
targeting their active sites or protein-protein interfaces via peptides and small-molecules have met with
significant challenges due to the need to compete with the native ligands, lack of well-defined binding pockets
in relatively featureless interfaces, or the inability to overcome the binding energy of proteins with small-
molecules. Motivated by these challenges, the overarching theme of this long-term MIRA research program is
to study a novel conceptual paradigm of targeting allosteric sites in selected proteins to achieve greater
compound selectivity and target specificity. Specifically, we will study three classes of proteins: (1) receptor
proteins from the hormonal and visual signaling pathways; (2) regulatory signaling proteins of the G-protein
family; and (3) protease enzymes from SARS-CoV-2, where allosteric modulation via peptides, non-covalent
and covalent small-molecules, and novel nanobodies is emerging. The discovery of these allosteric molecules
has opened the avenues for designing novel therapeutic agents for treatment of metabolic and mitogenic
diseases, cancers, and viral infections. In this project, we will conduct computational studies for characterizing
the binding modes and mechanisms of newly discovered insulin-like peptides from viruses and venomous
cone-snails as well as allosteric small molecules targeting extracellular and intracellular domains of
hormonal/growth-factor receptors, allosteric modulators of the catalytic domains of photoreceptor
phosphodiesterase, covalent allosteric small molecules targeting cysteine residues in regulatory signaling
proteins and viral proteases, and small allosteric nanobodies targeting viral proteases. We will develop and
employ a broad spectrum of computational methods spanning structural modeling, protein folding, molecular
docking, interface residue mapping, mutational energetics characterization, and enhanced sampling and will
integrate them with available experimental data. Overall, the research program will provide a strong basis for
establishing novel therapeutic approaches for initiating, inhibiting, activating, or modulating cellular signaling
outcomes.

Public health relevance
This project will use computational methods to elucidate the molecular basis of interactions between fast-acting and potent insulin-like peptides (VILPs and Con-Ins), allosteric small-molecules, and nanobodies with significant therapeutic potential for targeting cell-signaling proteins and enzymes implicated in the development of metabolic (e.g., diabetes), growth (e.g., cancer), neurological, and visual disorders. The project will enhance our understanding of interactions and mechanisms of modulation of various proteins, which is critical to accelerate the pace of discovery for designing novel targeted therapeutic approaches to address these urgent health needs.